Cross sensitization of diet and alcohol on binge behaviors and metabolic dysfunction

Project Summary/Abstract
Obesity and alcoholism are two of the most prevalent chronic diseases in the United States. These two diseases
may be linked as obesity and alcoholism share common behavioral characteristics, such as binge intake, and
are thought to utilize overlapping neural mechanisms. Additionally, obesity and alcoholism promote deficits in
insulin and glucose metabolism, early predictors of Type II diabetes. The goal of this project is to understand
how diets high in fat may interact with alcohol to worsen development and progression of both alcoholism and
diet-induced obesity related metabolic dysfunction in mouse models. Specifically, we will examine how eating
patterns can produce binge-type high fat diet food intake that may cross-sensitize to binge alcohol
consumption in a novel behavioral model of co-morbid diet and ethanol interactions in mice. We will then
examine the neurocircuitry involved in these binge intake patterns and determine the mechanisms by which
high fat diets and alcohol modulate critical brain cell populations. Based on our preliminary data, we propose
that high fat diet and alcohol consumption increase neuronal activation in the central nucleus of the amygdala
via modulation of neuroimmune cell function. Finally, we will examine the impact of co-morbid high fat diet
and alcohol consumption on insulin and glucose function and metabolism. In doing so, we will determine the
mechanisms by which key neurocircuitry involved in the central control on insulin release are altered by high
fat diet and alcohol. Specifically, we will be examining the mechanisms by which high fat diet and alcohol
consumption inhibit the activity of neuronal populations in the dorsal motor nucleus of the vagus nerve that
project to the pancreas and how this cell population is modulated by central amygdala inputs. These research
questions will be tested with a novel combination of electrophysiologic, immunohistochemical, opto- and
chemo- genetic, behavioral, and whole-animal physiology methods not typically seen within a single
application and examine diet and alcohol changes from the cellular level to whole animal function. These
studies will be of significant interest to the mission of the National Institute of Alcohol Abuse and Alcoholism,
and are of important relevance to FOA PA-17-211. Successful completion of these studies will provide new
understanding of the mechanisms involved in the disease progression of obesity and alcoholism as well as
uncover new potential targets for the treatment of both disorders, both singularly and in co-morbid situations.

Public health relevance
Project Narrative Obesity and alcoholism are two of the most prevalent chronic diseases in the United States, causing similar, and potentially interactive, behavioral and metabolic symptoms. This interaction may be caused by diet and alcohol mediated changes in brain regions controlling intake and insulin/glucose homeostasis. Utilizing a newly developed animal model of binge intake for both high fat diet and alcohol as well as a variety of cutting edge neuroscience and whole-animal testing techniques, we aim to understand how diet and alcohol interact to promote changes in cellular function in key brain regions and to determine novel targets for new treatments for these diseases, both singularly and concurrently. Successful completion of these studies will have broad- ranging impact to enhance overall health by reducing risk for obesity and alcoholism, and lessening the impact of these issues on subsequent chronic diseases, such as Type II diabetes mellitus and mental health outcomes.